Elucidating molecular mechanisms of lysosomal dysfunction underlying progranulin deficiency

PROJECT SUMMARY
Progranulin (PGRN) encoded by the gene GRN is a secreted pleiotropic protein implicated in several processes
including inflammation, extracellular signaling, and neuronal survival. Heterozygous, loss of function GRN
mutations cause the neurodegenerative disorder frontotemporal dementia (FTD). Genetic variants in GRN that
decrease circulating levels of PGRN also increase the risk of developing Alzheimer’s disease or Parkinson’s
disease. These genetic discoveries demonstrate that PGRN is important for neuronal health, but it is unclear
why the loss of PGRN leads to neurodegeneration. Interestingly, recently identified homozygous GRN mutations
cause neuronal ceroid lipofuscinosis (CLN11). This group of lysosomal storage disorders (LSD) presents with
neurodegeneration, cognitive deterioration, and lipofuscinosis in multiple tissues. The discovery that that
homozygous GRN mutations cause an LSD combined with the observation that FTD-GRN patients share CLN11
pathological features, strongly suggests lysosomal dysfunction may underlie both disorders. This proposal will
help elucidate the molecular role of Progranulin in the lysosome underlying mechanisms of neurodegeneration.
PGRN traffics to the lysosome where it is processed into subunit granulins. It has been suggested that
granulins are neurotoxic and pro-inflammatory, but recent work from the Kukar lab and others indicates that
granulins play a homeostatic role in the lysosome. Data shows that granulins are stable in the lysosome
compared to full length PGRN, and that granulins are decreased in human FTD-GRN cells and brain tissue.
Furthermore, the complete loss of PGRN and granulins leads to accumulation of ceramides in the brain. These
data suggest that granulins may be a bioactive component of lysosomal function involved in lipid degradation,
yet the ability of individual granulins to ameliorate phenotypes of PGRN deficiency in vivo in unknown. Aim 1 will
assess whether the expression of individual granulins is sufficient to rescue dysregulated lysosome function, and
inflammation in Grn-/- mice. Progranulin has been implicated in the inflammatory response and is highly
expressed in microglia, the brain’s resident immune cells. PGRN is involved in microglia activation, phagocytosis,
migration, and synapse pruning. Moreover, the loss of PGRN has been shown to cause early and selective
impairments in the maturation of lysosomal cathepsins, and accumulation of lipid droplets in murine microglia
suggesting that microglial lysosomes may be particularly vulnerable to the loss of PGRN. Homeostatic microglial
function is critical for brain health, however the impact of PGRN deficiency on human microglia is unknown. Aim
2 will assess the functional effects of PGRN deficiency on human microglia leveraging a novel patient derived
iPSC line and isogenic controls developed by the Kukar lab. These experiments will be the first to directly assess
the role of granulins on the molecular, and pathological, phenotypes of PGRN-deficient systems. Evaluating the
bioactivity of PGRN and granulins will elucidate disease-relevant molecular pathways, and lead to the
development of effective and precise therapeutics to treat diseases caused by PGRN/granulin deficiency.

Public health relevance
PROJECT NARRATIVE Loss of function mutations in the gene granulin (GRN) decrease levels of the protein progranulin (PGRN) and cause the neurodegenerative diseases frontotemporal dementia (FTD) and neuronal ceroid lipofuscinosis (CLN11). Although, lysosomal dysfunction is a common feature of PGRN deficiency disorders, the underlying function of PGRN and its constituent granulin subunits in the lysosome remains unclear. The aim of the proposed studies is to determine the molecular mechanisms underlying lysosomal dysfunction in models of PGRN deficiency.